CORE--LABORATORY CORE

The objective of the shared Core Laboratory of the Baylor Child Health Center is to facilitate the research activities of the new Program Development Project investigators (both funded and non-funded) and established researchers in the CHRC by providing core laboratory service to complement and extend their research capabilities in a cost effective manner. The shared core laboratory has developed a centralized resource consisting of state of the art equipment and skilled support staff. The following services are available in the core laboratory: Oligonucleotide synthesis DNA sequencing using a variety of DNA templates PCR support Computer and informatics support for detailed sequence analysis and data storage.